Circadian clock regulation of myocardial ion channel expression and function

Summary:
The overall objectives of this proposal are to 1) define the genomic and transcriptomic mechanisms by which
the cardiomyocyte clock regulates ion channels that contribute to cardiac excitability; and 2) disrupt the
cardiomyocyte clock to link changes in circadian-ordered gene expression with electrophysiological properties
of atrial and ventricular cardiomyocytes. The outcomes will address significant gaps in our understanding for
how the myocardial circadian clock regulates the expression of key cardiac ion channels and how abnormal
cardiac clock function contributes to arrhythmia vulnerability.
The mechanism regulating circadian timing, the molecular clock, exists in virtually all cell types in the body. A
critical function of the molecular clock is to link time of day with a large-scale transcriptional program to support
cellular homeostasis To date, our labs have used an inducible cardiomyocyte specific mouse model to knock
out the core clock gene, Bmal1 (iCSΔBmal1). These studies showed that disruption of the myocardial clock is
sufficient to decrease ventricular K+ and Na+ channel gene expression, disrupt current levels, disrupt cardiac
excitability, and increase arrhythmia susceptibility. These studies establish a critical role for the cardiomyocyte
clock, independent of the central clock, in regulating the expression of different families of ion channel genes
that impact the ionic balance needed for normal excitability. One goal of this project is to utilize large scale
genomic and transcriptomic approaches with our mouse model system to define the circadian clock dependent
control of temporal gene expression in both atrial and ventricular tissues.
To address abnormal circadian clock function, our lab has used different models of circadian disruption, such
as chronic phase advance or time restricted feeding to test links between circadian disruption and arrhythmia
vulnerability in mouse models. We have found that disrupting either light or feeding time cues is sufficient to
induce pathological changes in cardiac rhythms in normal mice and to accelerate sudden cardiac death in a
genetic mouse model of arrhythmia susceptibility. These studies support our premise that disruption of day-
night rhythms through environmental factors leads to altered myocardial clock function with outcomes that
include modified ion channel expression, cardiac excitability and arrhythmia vulnerability.
The aims of this proposal are designed to test the following hypotheses: 1) The molecular clocks in both atrial
and ventricular cardiomyocytes are necessary to direct daily chromatin accessibility and transcriptional output
including expression of key ion channel and ion channel regulatory genes. 2) Chronic disruption of the
cardiomyocyte clock using altered time of feeding is sufficient to cause dysregulation of the cardiac clock
resulting in an imbalance in cardiac ion channel expression and currents leading to altered excitability and
increased arrhythmia vulnerability.

Public health relevance
Narrative This project will discover the circadian clock controlled ion channel gene expression programs in both the ventricles and atria of the heart. These data will help define the molecular targets through which an abnormal circadian clock in the heart contributes to arrhythmia vulnerability. The outcomes of this study provide the translational framework to use circadian concepts as a disease modifier for at risk patient populations.